The Dynamics of DNA in Salmonella Persisters in Macrophages

Abstract
Bacterial persistence contributes to antibiotic treatment failure and the relapse of many recalcitrant
infections. Persisters are a subpopulation of transiently non-growing bacteria capable of surviving antimicrobial
attacks from antibiotics and the immune system and eventually resuming growth. Many pathogens including,
Salmonella enterica, Mycobacterium tuberculosis, and Staphylococcus aureus, form persisters within
macrophages where they survive extended periods of time. It was shown that, although non-growing, Salmonella
persisters retain the ability to express and inject effector proteins in macrophages leading to interference with
the host immune response and supporting persister survival. Nonetheless, persisters remain vulnerable to
macrophage-induced DNA damage in the form of double stranded breaks (DSBs) and require DSB repair
through homologous recombination. Strikingly, intramacrophage Salmonella persisters also actively replicate
chromosomal DNA and can accumulate more than four chromosome equivalents of DNA. I have found that
persisters replicate complete chromosomes despite growth arrest and that this chromosome amplification is
associated with a higher frequency of persister regrowth. I hypothesize that stresses encountered upon
macrophage entry trigger a specific state of growth arrest where atypical chromosome replication is enabled and
then favors repair of chromosomal DSBs by homologous recombination. To evaluate this hypothesis, I will
decipher the mechanisms and consequences of DNA synthesis in Salmonella persisters. In Aim 1, I will
characterize the contribution of chromosome amplification to homologous recombination and thus persister
survival. I will use gene conversion assays to measure homologous recombination in persisters with high DNA
content (1.1). I will then assess how DSB repair affects persister regrowth by tracking DSB repair using
fluorescent imaging and transcriptional reporters of the DNA damage response (1.2). In Aim 2, I will determine
the basis for DNA synthesis despite growth arrest including the requirements for initiation of DNA synthesis and
intramacrophage conditions that trigger this atypical DNA synthesis. I will determine the requirements for
initiation of chromosome replication at oriC through minichromosome replication assays (2.1). I will assess the
macrophage triggers for atypical DNA replication by evaluating DNA accumulation of persisters in genetically-
altered macrophages (2.2). Altogether, this research will further our understanding of intracellular persisters
including formation, maintenance of the persistent state, and re-growth. Mechanistic understanding of persister
survival will ultimately contribute to the development of approaches for targeting persisters, enhancing antibiotic
efficacy, and preventing the development of antibiotic resistance.

Public health relevance
Project Narrative Bacterial antibiotic persistence contributes to treatment failure, relapsing infections and selection of antibiotic resistance, yet mechanisms of persistence remain ill defined. In this project I will characterize properties and vulnerabilities of Salmonella persisters during infection to identify potential targets for their elimination. I will focus on the recent observation that chromosome accumulation confers a survival advantage to persisters and I aim at deciphering the benefit of such new genetic material.